Improving Contraceptive Care for Pregnancy-Capable Veterans with Autoimmune Conditions

PROJECT SUMMARY/ABSTRACT
Pregnancy-capable Veterans experience an elevated risk of adverse reproductive health outcomes relative to
the general population due to a high prevalence of comorbid mental, physical, and psychosocial conditions
influenced by trauma, combat exposure, and other experiences. Veterans' unique trauma and stress
experiences may influence the development or severity of other health conditions that pose issues for
reproductive health outcomes and care access, such as autoimmune conditions. Pregnancy, in particular, can
introduce elevated risks for people with autoimmune conditions because many are managed with teratogenic
medications, and pregnancy may exacerbate disease activity. Access to ongoing contraceptive care is
especially vital for people with autoimmune conditions because it allows them to mitigate the potential health
risks of pregnancy and control when they want to achieve pregnancy. These conditions often require regular,
ongoing care from multiple providers, which may lead to gaps in access and quality of wanted contraceptive
care. Subspecialists, who often provide most care for this population, may have limited expertise in
contraception and fear the possible implications of pregnancy for their patients. The underlying elevated risk of
adverse reproductive health outcomes coupled with the unique challenges of autoimmune conditions may be
further compounded by provider and facility-level characteristics for Veterans who use Veterans Health
Administration (VA), where pregnancy-capable Veterans remain a minority and availability and quality of
contraceptive care are variable. The VA is an ideal setting for studying contraceptive care delivery for this
population due to the system’s size, comprehensive electronic health record (EHR), and diverse patient
population. The proposed mixed methods study aims to examine the potential multi-level quality and access
barriers to contraceptive care delivery to Veterans with autoimmune conditions using three different data
sources. First, differences in documented procedural or prescription contraception will be investigated for
Veterans with the most prevalent autoimmune conditions compared to those without these conditions using
structured EHR. Hierarchical modeling will identify facility, provider, and patient-level factors associated with
the documentation of a method. Second, novel natural language processing software and qualitative analytical
methods will be applied to unstructured EHR clinical notes to characterize contraceptive care for Veterans
without a documented method to explore contributors to the lack of documentation, such as poor care quality
or lack of need. Third, the findings from the first aims of the project will be further contextualized by conducting
qualitative interviews with Veterans with autoimmune conditions with and without documentation of
contraception to characterize access and quality barriers to receiving desired contraceptive care. The results
from these aims can provide evidence of potential issues with contraceptive care delivery for Veterans with
autoimmune conditions and offer actionable steps for improving VA policy and practice related to this care.

Public health relevance
PROJECT NARRATIVE Pregnancy-capable Veterans experience an elevated risk of adverse reproductive health outcomes compared to the civilian population because of a confluence of trauma, combat exposure, and other exposures that may affect health outcomes and the development of comorbid mental, physical, and psychosocial conditions, such as autoimmune conditions. The proposed mixed methods study aims to understand and triangulate the multi- level quality and access barriers to contraceptive care Veterans with autoimmune conditions may experience using three different, rich Veterans Health Administration data sources: electronic health record data, medical record text notes, and qualitative interviews. The results from the proposed research will provide a strong foundation for developing interventions and policies to promote high-quality contraceptive care for a population at high risk of adverse reproductive health outcomes.